FIGOR: Fellowship In Genomics Outcomes Research

Genetic counselors have rigorous training in genetics and extensive skills in communicating the impact of genetic disease while facilitating coping. There are ~ 6,000 Certified genetics counselors who work in broad areas of medicine and science. The Fellowship in Genomics Outcomes Research (FIGOR) pairs genetic counselors seeking additional training and mentorship in research with leading scientists in genomic research. Facilitating genetic counselors' involvement in research will enhance the quality of the science of genomic and personalized medicine through interdisciplinary collaborations. We request funding for 7 genetic counselor scholars who would each commit to 0.5 FTE of research over 24 months. The long-term goal is for these genetic counselors to contribute as investigators to genomic research by seeking funding, conducting and collaborating in research, and presenting and publishing translational research beyond the clinical spaces where genetic counselors have typically contributed. The training begins with exploration of research opportunities and development of an individualized research plan. Included in the research plan is an educational plan which outlines their timeline and tasks to gain the skills necessary for their research. Students will interact with leaders in genomic and personalized medicine through their collaborations, research seminars, and attendance at national meetings. This measured and focused timeline will allow scholars to craft an immersive experience while benefiting from the unique and plentiful resources at Vanderbilt including BioVU, the Data and Research Center for NIH’s “All of Us”, the Undiagnosed Disease Program, eMERGE, and the ICARE registry. With the establishment in 2015 of the Vanderbilt Genetics Institute, Vanderbilt has committed substantial resources for recruitment of collaborative faculty at Assistant, Associate and Professor levels in genetics and genomics. The Vanderbilt Master of Genetic counseling degree program has demonstrated how GCs are successfully engaged in research at Vanderbilt. Of the 11 recent graduates 9 have presented at national or international meetings. Graduates have published 5 articles in 3 different journals. Skills-focused classroom instruction will complement experienced-based learning through research and active collaboration with experienced mentors. Through these collaborations both the mentee and the mentors will contribute to the growth of genomic research outcomes for personalized medicine.

Public health relevance
The purpose of the Fellowship In Genomics Outcomes Research (FIGOR) is for Genetic Counselor Scholars (GCS) to experience mentored research in a highly collaborative and supportive environment with 50% effort protected time for 24 months. GCS will gain experience in translational research skills in the areas of genomic sciences and genomic medicine, as well as the ethical, legal and social implications of these areas. The experience will simultaneously educate genetic counselors and scientists in the value of collaboration to maximize and broaden the impact of translational research.